7th International Enteric Nervous System Development Meeting: Connection, Cross-talk and Collaboration

Project Summary/Abstract
In the past several decades, researchers have made extraordinary progress in our understanding of enteric
nervous system (ENS) development and function. Vital scientific advances have occurred in identifying the
major signaling pathways, transcription control, migratory behavior, enteric neuronal and glial subtypes,
microenvironmental factors, genetics, and neurotransmitter physiology require for normal ENS development.
This exponential growth in scientific contributions to the field of ENS development has greatly enhanced our
understanding of Hirschsprung's disease, the most common congenital enteric neuropathy, and has informed
recent studies in the generation of neuronal stem/progenitor cells for cell-based regenerative medicine
therapies to treat enteric neuropathies.
The first international ENS development meeting occurred in New York in 2006, supported in part by a R13
grant from the NIH. This triennial meeting was subsequently held in London (2009), Hong Kong (2012),
Rotterdam (2015), Boston (2018), and Ferrara (2022). The symposium is truly bench to bedside, bringing
together bench researchers such as molecular and cellular biologists, geneticists, physiologists, and stem cell
investigators and bedside clinicians such as gastroenterologists and surgeons, who all share a common
interest in the development and function of the ENS and improving current management for enteric
neuropathies. All of the ENS development meetings have been quite successful, with a growing number of
attendees from 130 to nearly 200 in recent years from over 20 different countries in 5 continents from around
the world. The 7th International Enteric Nervous System Development Meeting: Connection, Cross-talk and
Collaboration will be held in Philadelphia in March 2024. This will be the first meeting focused on ENS
development held in the U.S. since the COVID-19 pandemic and builds upon the success of prior meetings as
well as the growing significance and relevance of ENS research.
The specific aims of this R13 application are 1) to encourage and inspire the participation of young
investigators, especially groups under-represented in science such as women, minorities, and
socioeconomically disadvantaged individuals at this 7th International ENS Development Symposium by
offering 20 Travel Awards to offset registration costs and travel expenses as well as 12 Scientific Merit Awards
to highlight and promote accomplished young investigators; and 2) to improve the likelihood of long-term
success for young investigators pursuing academic careers in the field of ENS development and function by
establishing lasting mentored relationships with select faculty and members of the meeting’s International
Organizing Committee. We anticipate that this unique ENS Development meeting will build meaningful
mentorship and collaborations that will enhance the career development of the award recipients.

Public health relevance
Public Health Relevance The 7th International Enteric Nervous System Development Meeting: Connection, Cross-talk and Collaboration brings together cutting edge bench scientific research with current bedside clinical management, and includes a diverse group of geneticists, molecular and cellular biologists, physiologists, pathologists, physicians (gastroenterologists and surgeons), and stem cell researchers, who all share a common interest in the development and function of the enteric nervous system (ENS) as well as the treatment of neurointestinal diseases. A major goal of this conference grant is to increase the participation of young investigators, especially from groups traditionally under-represented in science such as women and minorities. This grant will support Travel Awards and Scientific Merit Awards for these bright young scientists and foster mentoring relationships that will give them invaluable opportunities and improve their likelihood of future success.